Technology Core

Summary/Abstract
The Broad’s GCID will make breakthrough progress by testing key hypotheses and filling fundamental
knowledge gaps about the mechanisms responsible for infectious diseases. We will do this by
generating and analyzing ‘omic data from a variety of key pathogens and characterizing key
interactions between pathogens and their hosts. To drive this mission, we have created a Technology
Core that brings an unmatched combination of cutting-edge capabilities for the study of pathogens —
including viruses, bacteria, fungi, parasites and their vectors — and their hosts. The Technology Core
will generate a variety of high throughput data, from a wide range of sample types, utilizing our state-of-the-art genomics facility. To do this, we will draw upon our expertise operating, managing and
optimizing robust, large- and small-scale data generation processes, and on our extensive and
sophisticated sample handling and tracking capabilities. We will improve existing methods to increase
their utility in our studies, for example by reducing to practice new enabling methodologies, enabling
increased scale and efficiency, improving data quality and decreasing costs. We will enhance our
approaches to pathogen hybrid selection and long read sequencing, and also implement new protocols
for low input RNA- and metagenomic-sequencing. Finally, building on our long track record of
innovation in genomics, we will create new technologies and establish new capabilities that were not
previously practical or possible to open new fundamentally avenues for our Research Projects. These
include systematic methods to study gene function, to enrich pathogen nucleic acids from those of the
host, and to sequence from single cells, as well as methods for simultaneous capture of genomes and
plasmids from single cells and ribosome profiling proteomics. Importantly, the technical expertise of the
Technology Core is closely integrated with the mechanisms of oversight and management of the
Administrative Core. Collectively our GCID will apply these methods to understand mechanisms of
virulence, transmission and drug resistance, to define the critical interactions between pathogens and
their hosts and microbial communities to improve our prevention, diagnosis and treatment of infectious
diseases.